ROR1 as a Therapeutic Target in Acute Lymphoblastic Leukemia

PROJECT SUMMARY/ABSTRACT This application addresses Program Announcement Number: PA-09-036, NIH Pathway to Independence Award (K99/R00). Candidate: Dr. Jeffrey Tyner has been training in the field of molecular and cellular biology research for the past 15 years as a summer student (Purdue University), undergraduate research assistant (Grinnell College), graduate student (Washington University in St. Louis), and post-doctoral fellow (Oregon Health & Science University). He has studied a diverse spectrum of biological fields including botany, immunology, microbiology, and hematology/oncology. This research has led to 21 cumulative published manuscripts in high-impact journals such as Nature Medicine, Journal of Clinical Investigation, Cancer Research, Proceedings of the National Academy of Science, and Blood as well as numerous other manuscripts in revision or preparation. Dr. Tyner has also presented his work in oral presentations and poster sessions at major national conferences. The theme of Dr. Tyner's research involves the identification of target oncogenes and oncogene-specific therapeutics, such that cancer therapies can be tailored to each individual patient. To accomplish these goals, he has created two screening techniques that make use of siRNA or small-molecule kinase inhibitors to identify functionally important target genes for follow-up characterization and genomic study. Using these techniques, he has identified a gene, ROR1, that is a candidate therapeutic target in all acute lymphoblastic leukemia patients with a 1;19 chromosomal translocation. This proposal aims to characterize the mechanisms of overexpression and signaling of this target gene and to identify gene-specific modalities for therapeutic intervention. Dr. Tyner's long-term career goals include establishment of an independent research lab with a focus on cancer research and personalized medicine. Environment: The Oregon Health & Science University Knight Cancer Institute has 165 primary faculty investigators who have expertise across a diverse spectrum of fields of inquiry. Dr. Tyner's mentor, Dr. Brian Druker, is the Director of the Knight Cancer Institute. Dr. Druker has over 20 years of experience in the field of cancer research and has mentored numerous students and fellows to independent investigator status. This proposal also includes statements of support from Dr. Richard Goodman, Dr. Philip Streeter, and Dr. Robert Searles. Cumulatively, these supporting scientists as well as the Knight Cancer Institute as a whole posses all the instrumentation, resources, and expertise to carry out the research proposed in this application. Research: Specific targeting of oncogenic signaling pathways with kinase inhibitors has vastly improved clinical outcomes for patients with a variety of cancer diagnoses, most notably patients with chronic myeloid leukemia. To expand this targeted-therapy approach to all forms of cancer, disease-causing genes must first be identified and characterized. Towards that end, we have developed an RNAi-based screen to rapidly identify target genes in primary cancer cells obtained directly from leukemia patients. Using this screen, we have identified a receptor tyrosine kinase, ROR1, that is uniquely and consistently overexpressed in all patients with t(1;19)-positive acute lymphoblastic leukemia (ALL), representing approximately 5% of all pediatric ALL and 1-2% of adult ALL cases. Silencing of ROR1 results in significantly decreased viability of t(1;19)-positive ALL cells, but has no effect on viability of other pediatric ALL cells or normal white blood cells. In addition, previous studies of chronic lymphocytic leukemia (CLL), which accounts for approximately 30% of adult leukemia cases, have identified ROR1 overexpression in the majority of cases. Validation of ROR1 as a bona fide therapeutic target necessitates a better understanding of the mechanisms of genetic regulation and signaling by which ROR1 contributes to cellular transformation. However, very little is known about the regulatory elements governing ROR1 expression or the signaling pathways employed by ROR1 to influence cellular viability, and there are currently no available strategies by which ROR1 can be therapeutically targeted. The finding of ROR1 overexpression and ROR1-dependence in t(1;19)-positive ALL cells offers unique tools to study this problem. We propose that a multi-pronged approach to studying 1) regulation of ROR1 expression, 2) signaling mechanisms through which ROR1 contributes to transformation, and 3) development of therapeutic strategies for inhibiting ROR1 will elucidate the disease pathogenesis of ROR1-dependent malignancies such as t(1;19)-positive ALL or CLL and offer new strategies for therapeutic intervention in these patients.

Public health relevance
PROJECT NARRATIVE We have found that the receptor tyrosine kinase, ROR1, is uniquely and consistently overexpressed on cells from t(1;19)-positive acute lymphoblastic leukemia (ALL) patients. Expression of ROR1 is required for viability of 1;19-positive cells making it a novel therapeutic target for these patients. Elucidation of the mechanisms underlying ROR1 expression and signaling in t(1;19)-positive ALL will lead to more comprehensive understanding of disease pathogenesis and offer insights into new strategies for therapeutic intervention. __SpecificAimsTextDelimiter__ SPECIFIC AIMS We have used an siRNA screen to identify the receptor tyrosine kinase, ROR1, as a gene target in acute lymphoblastic leukemia (ALL) patients harboring a 1;19 chromosomal translocation, which creates the chimeric transcription factor E2A-PBX1. Silencing of ROR1 results in markedly decreased viability of early passage xenograft cells as well as cell lines derived from t(1;19) patients offering unique tools to dissect the mechanism of ROR1 overexpression, signaling, and its potential as a cancer therapy target. We will explore the mechanism causing ROR1 overexpression by analyzing global transcriptional targets of E2A-PBX1 and identifying critical regulatory elements of the ROR1 promoter. We will investigate the upstream and downstream signaling pathways linking overexpressed ROR1 with cell viability. Finally, we will explore strategies to therapeutically target ROR1 including small-molecule kinase inhibitors and neutralizing antibodies. Aim 1. Mechanism of ROR1 overexpression A. E2A-PBX1 is the fusion gene product of the 1;19 translocation. We will perform Chromatin Immunoprecipitation (ChIP-Seq) experiments on cells expressing endogenous or epitope-tagged E2A- PBX1 to identify its transcriptional targets, with a special focus on targets that bind the ROR1 promoter. B. We will identify the minimal promoter element necessary for ROR1 expression and subsequently perform a detailed deletion analysis to characterize the regulatory elements necessary for ROR1 overexpression. Aim 2. Signaling of ROR1-induced transformation in t(1;19)-positive ALL cells A. Upstream: We will determine the ligand(s) involved in activating ROR1 with a special focus on WNT16B and other members of the WNT family. B. Downstream: We will determine the cytosolic signaling cascade linking ROR1 with cell viability with an emphasis on activation of the β-catenin, JNK, SRC-family, and NF-κB pathways. Aim 3. Therapeutic strategies for clinical targeting of ROR1 A. We have screened a panel of kinase inhibitors for activity against t(1;19)-positive cells and identified three candidates. We will characterize the capacity of these drugs to inhibit ROR1 or its signaling partners. B. We will develop and test ROR1 neutralizing antibodies for therapeutic efficacy on t(1;19)-positive cells.